OurSleepKit: A Couple-focused mHealth Tool to Support Adherence to CPAP Treatment

PROJECT SUMMARY
Poor adherence to continuous positive airway pressure (CPAP) treatment remains the single largest
impediment to effective management for obstructive sleep apnea (OSA) leading to increased morbidity,
mortality, and higher health care costs. Existing interventions promoting CPAP adherence focus only on the
diagnosed individual and are delivered mostly by health professionals, with limited success. As supported by
the findings of the PI’s R15 project, the partners of patients play a significant role – either positive or negative –
in CPAP adherence, and are part of all of the major facilitative aspects and barriers to CPAP use. A dyadic
approach engaging both the patient and partner to promote CPAP adherence remains an untapped
opportunity. Our interdisciplinary team has developed a prototype of OurSleepKit, which is an innovative
couple-focused mHealth tool to promote CPAP adherence. Guided by the conceptual framework of partner
involvement in CPAP adherence, the goal of OurSleepKit is to coach mutual engagement and model positive
partner involvement in CPAP treatment, thus motivating greater CPAP adherence. Responding to the PA-18-
722, the goal of this R01 project is to refine and test OurSleepKit to support adherence to CPAP treatment. We
will refine and deploy OurSleepKit on an established secure mHealth platform, NUCoach. Getting users to
engage with an mHealth intervention is critical to its success, and low user engagement with existing mHealth
tools remains a big concern. To address this issue, we will use a participatory approach to refine OurSleepKit
and comprehensively evaluate both its effect on CPAP adherence and user engagement. Specifically, we will
1) Refine OurSleepKit using qualitative methods within a standardized iterative participatory approach by
working with end users (OSA patients and their partners); 2) Examine the effectiveness of OurSleepKit on
CPAP adherence by conducting a 6-month randomized parallel group controlled trial in 180 couples (newly
diagnosed OSA patients and their partners); and 3) Evaluate user engagement in the intervention group by
tracking objective OurSleepKit usage and understanding the subjective user experience. Results of this project
will support the development of an effective and engaging mHealth tool which can be readily adopted by OSA
patients and their partners to support adherence to CPAP treatment. Given the frequency and depth of
interaction that most patients have with their partner, OurSleepKit is likely to succeed with a sustainable effect
on CPAP adherence leading to significant health benefits. If shown to be successful, OurSleepKit can be easily
integrated with other interventions and existing technology to better promote CPAP use. This new mHealth
intervention facilitates changing the current care of OSA from a reactive disease-focused model to a more
proactive self-management model. Going beyond OSA, OurSleepKit can be an exemplar of using mHealth
technology to optimize treatment adherence and self-management involving family care partners.

Public health relevance
Project Narrative Obstructive sleep apnea (OSA) is a growing and serious worldwide health problem with significant health and socioeconomic consequences. Poor adherence to continuous positive airway pressure (CPAP), the primary treatment option for OSA, is associated with increased morbidity, mortality, and health care costs, and has been a major obstacle in the effective management of OSA. This project addresses the critical need to improve CPAP adherence by refining and testing an innovative couple-focused mobile health intervention.